Characterizing the Neural Pathway Maintaining Urinary Continence and its Role in Hydrocephalic Incontinence

ABSTRACT
Urinary urge incontinence affects nearly 20 million Americans, causing loss of independence and feelings of
depression. Among those affected, are patients with Normal Pressure Hydrocephalus (NPH), who experience
urge incontinence as one of three symptoms. Despite large economic and caregiver burden associated with
incontinence, little is known about the neural pathway responsible for control of continence or how this pathway
may be disrupted in NPH. The overall objective of this project is to identify this pathway and determine how it is
altered in NPH. Barrington’s nucleus (Bar) in the dorsal pons is considered the micturition center, as it facilitates
voiding in response to input from the periaqueductal gray (PAG), which signals bladder stretch. However, this
reflex does not explain complex micturition behaviors, like continence, for which other brain regions must be
involved. Imaging studies of the medial prefrontal cortex (mPFC) show that this area is involved in micturition
and mPFC hypoperfusion in NPH or strokes to this region are associated with incontinence. Additionally, lesions
to the preoptic area of the hypothalamus (POA) can also produce incontinence. Furthermore, the POA receives
input from the mPFC and sends output directly to Bar. This data suggests a role for both the mPFC and POA in
continence control. Our central hypothesis is that the pathway maintaining continence connects excitatory
neurons in mPFC to Bar via inhibitory relay neurons in POA, and that disruption of this pathway in the
periventricular white matter causes incontinence in NPH. To test this hypothesis, we propose the following aims:
1) Characterize the role of the mPFC → Bar pathway in micturition. I will test the hypothesis that this pathway is
necessary for maintaining continence and that stimulation of the latter half of this pathway is sufficient to restore
continence. First, I will combine anterograde tracing with immunohistochemistry to identify this multi-synaptic
pathway. Secondly, I will test this pathway’s function by lesioning the mPFC and stimulating POA terminals in
Bar. We hypothesize that the lesions will create incontinence and the stimulation will restore continence.
2) Identify and overcome differences in NPH incontinent mice. We have already created a progressive
hydrocephalus in mice that is often accompanied by incontinence. I will expand this study by assessing the tissue
of these incontinent mice for axonal injuries, hypothesizing that we will see demyelination in the white matter
tracts connecting the mPFC to the POA, running alongside the ventricles. Then we will stimulate POA terminals
in Bar in these mice. We hypothesize that stimulation here will improve incontinence caused by hydrocephalus.
By the end of this project, I will have identified the pathway connecting the medial prefrontal cortex to Barrington’s
nucleus, determined its role in the maintenance of continence, identified structural differences of this pathway in
mice with hydrocephalus, and manipulated this pathway to restore continence to incontinent mice. This work will
expand current treatment options for patients suffering from incontinence, both with and without NPH, by
identifying new therapeutic targets.

Public health relevance
PROJECT NARRATIVE Urinary incontinence is a devastating condition that affects an ever-growing number of people, including those with normal pressure hydrocephalus (NPH). Unfortunately, we lack understanding of the basic neural pathway responsible for the maintenance of continence and how it is disrupted in NPH. Identifying this pathway and its role in NPH incontinence may lead to life changing treatments for these patients.